Chemical Genetic Dissection of SWI/SNF Chromatin Remodeling Complex Functions in Cerebral Cortex Development

PROJECT SUMMARY/ABSTRACT
Intellectual Disability (ID) and Autism Spectrum Disorders (ASD) are the most common developmental
disorders, affecting 3-4% of children in the U.S, with few therapeutic options. Although insights into the
mechanisms that cause these heterogeneous disorders remains very limited, genetic studies of ID/ASD have
revealed a central role for mutations in genes encoding transcriptional regulatory proteins, including multiple
subunits of the SWI/SNF ATP-dependent nucleosome remodeling complex (BAF complexes). For example,
heterozygous loss-of-function mutations in Arid1b, the largest subunit of the canonical BAF complex (cBAF),
are among the most frequent mutations observed in de novo ID/ASD cases. However, the function of
ARID1B/cBAF complexes in gene regulation during normal brain development and the specific developmental
processes that are disrupted by Arid1b loss-of-function mutations remain significant gaps in knowledge.
Characterizing the specific functions of transcriptional regulatory complexes in cell type-specific gene
regulation in the dynamic and heterogeneous cellular environment of the embryonic brain remains difficult
using current model systems and experimental tools. Our long-term goal is to develop pluripotent stem cell-
based model systems and experimental tools to characterize gene regulatory networks that control cell fate
specification during brain development. Towards this end, my lab recently developed a robust, reproducible
protocol to make forebrain organoids from mouse pluripotent stem cells. This reduced complexity model
maintains key features of the developing brain and can enable experimental approaches that are not possible
in vivo. Here, we propose to 1) perform the first in depth transcriptomic and epigenomic characterization of
cerebral cortex development in our novel mouse organoid model using single cell genomics approaches, 2)
define the impact of Arid1b loss-of-function mutations on cortical development in vivo and in organoids, 3)
implement chemical genetic approaches (dTAG) to parse stage-specific effects of ARID1B loss, 4) define
direct effects of ARID1B loss on gene regulation during cortical development, 5) determine which gene
expression changes are reversible upon reintroduction of ARID1B into post-mitotic cortical neurons. These
data will help to establish mouse cortical organoids as a model system that can complement and extend upon
in vivo approaches for studying molecular and cellular mechanisms of brain development. Our findings will
provide new insight into the mechanisms by which loss-of-function mutations in Arid1b give rise to changes in
gene regulation during early stages of cortical neurogenesis and reveal specific genes, cell types, and
developmental stages that are susceptible to reduction of cBAF complexes. Given the relevance of this
complex to common developmental disorders, our findings may also reveal novel therapeutic opportunities for
ID and ASD.

Public health relevance
PROJECT NARRATIVE Intellectual Disability (ID) and Autism Spectrum Disorders (ASD) are the most common developmental disorders, affecting ~3-4% of children in the U.S. Human genetics studies have revealed that mutations in subunits of the SWI/SNF chromatin remodeling complex are recurrently mutated in individuals with ID/ASD. The proposed study will develop new model systems and experimental tools to study the function of SWI/SNF chromatin remodeling complexes during normal brain development to help understand the specific changes that occur during brain development in children with ID/ASD and to inform development of new therapeutic approaches.